Toward Selective Androgen Deprivation by Targeting Androgen Activation of SRF

Project summary/Abstract
Despite the central role of androgen receptor (AR) in prostate cancer (CaP) progression, insights into the specific
molecular mechanisms by which AR controls the cellular processes that drive CaP progression remain largely
elusive. Lack of this knowledge is an important problem, because without it, development of novel therapeutic
approaches that target specifically AR-dependent events underlying the lethal phenotype is unlikely. The long-
term goal is to understand how the mechanism(s) by which AR controls clinically relevant gene expression in
CaP cells can be manipulated for therapeutic intervention. The objective here is to determine the therapeutic
potential of disrupting AR-responsive PKN1-SRF interactions. The central hypothesis is that targeting PKN1
will prevent CaP progression mediated by AR-responsive SRF action. This hypothesis is formulated based on
preliminary work produced in the applicant's laboratory. The rationale for the proposed studies is that, once it is
understood how AR regulation of SRF action in CaP occurs, select targeting of AR action that is relevant to
disease progression will be possible. The central hypothesis is tested by pursuing 3 specific aims: 1) determine
the role of PKN1 in the AR-responsive SRF transcriptional complex; 2) define the substrate for PKN1's kinase
action in the AR-dependent SRF transcriptional complex; and 3) determine therapeutic potential of targeting AR-
responsive PKN1-SRF interactions. Aim 1 will determine the impact of genetic or pharmacological inactivation
of PKN1 on the composition and function of AR-dependent SRF complex at target genes using a combination of
RNA-Seq, ChIP-Seq and ATAC-Seq assays. In Aim 2, state-of-the-art biotin-based proximity ligation assays
and mass spectrometry in CaP models that express wild-type or kinase-dead PKN1 or in which PKN1 action is
pharmacologically inhibited will define PKN1-dependent phosphorylation of SRF, the SRF transcriptional
complex and its chromatin environment. Aim 3 will determine the therapeutic potential of inhibiting PKN1-SRF
interactions in clinically relevant PDXs and fresh ex vivo explants of CaP tissue obtained from patients. Clinically
applicable biomarkers of response to such treatment will be sought using gene expression and proximity ligation
assays. The proposed research is innovative because it focuses on an entirely different approach to target AR
action in CaP: unraveling and targeting an AR-dependent signaling pathway downstream of AR that controls the
expression of genes that are relevant for CaP progression. This contribution is significant because is it the first
step in a continuum of research that is expected to lead to the development of novel treatment modalities that
target specifically AR-mediated gene expression that underlies the lethal CaP phenotype. With respect to
expected outcomes, the proposed studies will identify the molecular mechanisms by which PKN1 introduces a
therapeutic vulnerability in the AR-PKN1-SRF signaling cascade that gives rise to the aggressive CaP
phenotype. These results will have an important positive impact because they will fundamentally advance
knowledge about AR action in CaP, in general, and provide new targets for CaP therapy, specifically.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because insights into the specific molecular mechanisms by which androgens control prostate cancer (CaP) progression are ultimately expected to provide the foundation to develop novel treatment options that are tailored to the specific AR-dependent events that underlie the lethal phenotype of CaP, a malignancy that causes more than 30,000 deaths annually in the US. Thus, the proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce the burdens of human cancer.